Disparities in Deaths of Despair and Violence and Tropical Cyclones in the United States

PROJECT SUMMARY
The United States is grappling with the urgent challenge of worsening mental and behavioral health
outcomes, with over 4 million deaths from suicide, assault, and psychoactive drug use in the past four
decades. These deaths, referred to as deaths of despair and violence, account for 5% of all US deaths and
are increasing faster than population growth. Significant disparities exist across sociodemographic groups,
with young adults, lower-income communities, and non-white populations experiencing worse outcomes,
including higher rates of stress, anxiety, depression, and suicide. Climate-related stressors, such as tropical
cyclones, further exacerbate mental health issues, potentially leading to increased rates of anxiety disorders,
intimate partner violence, and drug use behaviors. Tropical cyclone exposure is plausibly linked to deaths of
despair and violence through biological, mental, environmental, and socioeconomic impacts. Major
hurricanes often result in trauma, conflict, property loss, injury, and displacement, which can lead to suicidal
or violent behavior and substance misuse. As climate change intensifies, increasing the frequency and
severity of tropical cyclones, disparities in mental health outcomes are expected to worsen. There are critical
knowledge gaps in understanding the trends and disparities in deaths of despair and violence, the short-term
impacts of tropical cyclone exposure, and the long-term effects on vulnerable populations. In this supplement,
we will leverage data and methodology prepared for the parent R00 grant. To address these gaps, we will
analyze comprehensive mortality data and tropical cyclone exposure records. Our team, experienced in
environmental epidemiology and advanced statistical methods, will investigate the links between tropical
cyclone exposure and psychological distress-related deaths. Aim 1 will characterize long-term trends and
disparities in deaths of despair and violence by modelling trends in suicide, assault, and psychoactive drug-
related deaths from 1982 to 2022 and analyzing disparities by age, sex, race/ethnicity, and county. Aim 2 will
determine the short-term association of tropical cyclone exposure with deaths of despair and violence by
estimating death rate ratios by county-month following cyclone exposure from 1988 to 2022. Aim 3 will
evaluate the long-term impact of recurrent tropical cyclone exposure on these deaths and disparities by
utilizing synthetic control methods to estimate long-term effects and examine impacts by Social Vulnerability
Index scores. This project complements and extends the parent R00, and is consistent with NIH and Surgeon
General priorities, aiming to inform public health strategies, improve disaster response, and enhance mental
health resources for vulnerable communities. This research will provide the candidate with advanced skills,
training and research opportunities to a graduate student training in environmental epidemiology as applied
to climate and health. This supplement will also enhance diversity in our research team at Columbia
University and more broadly in the field of environmental health sciences at large.

Public health relevance
PROJECT NARRATIVE The United States faces a critical challenge with climate change and worsening mental and behavioral health outcomes, with over 4 million deaths from suicide, assault, and psychoactive drug use in the last four decades, constituting 5% of all deaths. Disparities persist across sociodemographic group; climate-related stressors, particularly tropical cyclones, significantly influence mental health, potentially leading to anxiety, PTSD, intimate partner violence, and drug use behaviors. This project aims to characterize long-term trends and disparities in these deaths, assess the short-term impact of tropical cyclones, and evaluate the long-term effects of recurrent tropical cyclone exposure, leveraging robust data and advanced statistical methods to inform public health strategies and prioritize mental health resources for vulnerable communities.